Linking epigenetics to electrophysiology using high-throughput microelectrode array-based hardware with simultaneous optogenetic activation

SUMMARY
Post-mitotic neurons in the mammalian brain form synapses that dynamically remodel
throughout an individual's lifetime to encode learning and memory. Synaptic plasticity
requires spatiotemporal fine-tuning of gene expression in response to neural activity,
including rapid transcription of immediate early genes on the time scale of minutes and
longer-term chromatin remodeling to promote transcription of secondary response genes
on the time scale of hours. In human systems, it is not possible to simultaneously measure
epigenetic features and electrophysiology from the same batch of neurons. However, now
with the emergence of reproducible protocols for human induced pluripotent stem cell
(iPSC)-derived neurons and iPSC-derived human brain organoids, it is possible to do
epigenetic studies on the human brain in vitro. At the current time, the gold-standard for
measuring electrophysiological properties in human cultured neurons and organoids is
the microelectrode array (MEA) technology coupled with hardware for simultaneous
optogenetic activation of neural circuits, however no such system is readily available in
the Department of Genetics at the University of Pennsylvania. There is a large group of
investigators working on neuroepigenetics at UPenn, and access to the MEA system will
empower the labs to achieve their overarching goal to conduct human studies linking
epigenetic features to neuronal functional electrophysiological properties that are
traditionally difficult to measure. Over the long-term, the ability to link neural circuit firing
and function to epigenetic signatures will shed light on how genetic and epigenetic defects
can cause functional defects in key neural circuit defects in human neurodevelopmental
and neurodegenerative disease.

Public health relevance
NARRATIVE Numerous neurological disorders, such as Alzheimer's disease and fragile X syndrome, exhibit defects in epigenetic modifications and neural circuit function, yet the link between the two length scales of brain biology is poorly understood. Here, we propose to acquire equipment to allow for simultaneous optogenetic activation, measurement of electrophysiological properties, and assay of epigenetic features within the same sample of cultured human neurons or human brain organoids.